Online assessment and enhancement of auditory perception for speech sound errors

Project Summary/Abstract
Children diagnosed with speech sound disorder (SSD) demonstrate atypical speech patterns that impact speech
intelligibility, creating obstacles to their engagement in both social and academic environments [1]. Delayed
speech development typically resolves by the age of 8-9; however, approximately 2-5% of individuals exhibit
residual speech sound disorder (RSSD), which can persist into adolescence or adulthood despite years of
intervention. RSSD primarily affects late-developing sounds such as the American English rhotic /ɹ/ and sibilants
/s/. Previous research, including our work in the past funding cycle, indicates that children with RSSD typically
exhibit reduced auditory-perceptual acuity for the sounds they produce in error. This implies that interventions
designed to enhance auditory targets and provide feedback on error sounds could improve treatment outcomes
for RSSD. One such intervention is biofeedback, in which learners view a real-time display of the acoustic signal
of their speech compared to a target representing the desired output. Biofeedback has shown promising results
in individuals with RSSD who have not responded to previous treatments [2, 3]. Another well-studied approach
seeks to enhance the auditory target for error sounds by presenting a wide range of productions and training the
child to classify them as correct or incorrect [4-6]. The present proposal is centered on exploring the relationship
between these two auditory-enhanced treatment methods for American English /ɹ/ while also extending the use
of biofeedback to another frequently misarticulated sound category, the sibilants.
The overall objective of this proposal is to expand our basic understanding of perception-production relations
in child speech while evaluating whether tasks involving perceptual training and visual-acoustic biofeedback are
valid in the online modality. In Aim 1, we will evaluate the extent to which a period of perceptual training can
enhance response to biofeedback treatment via telepractice. Aim 2 will use a single-case experimental design
to test the hypothesis that biofeedback treatment via telepractice can be successfully expanded to include the
sibilant /s/, a common target for children with RSSD that presents novel technological challenges for remote
service delivery. Our central hypothesis is that gains associated with biofeedback treatment will be enhanced
when perception training precedes production training and that biofeedback intervention for sibilants will yield
statistically and clinically significant treatment effects in the telepractice context.
This research will continue to advance the evidence base by contributing the first studies investigating the
efficacy of integrated auditory-perceptual training and biofeedback treatment in the telepractice context. This
research is also pioneering as it represents the first systematic effort to measure the efficacy of biofeedback
using a Fast Fourier Transform (FFT) spectrum to display sibilant sounds. Overall, the proposed research is
optimally positioned to make a high-impact contribution as new technologies reshape the nature of scientific
research and treatment delivery in speech pathology.

Public health relevance
Project Narrative In the post-COVID era, adoption of telepractice delivery of speech intervention has continued to grow due to its greater flexibility and efficiency and its ability to enhance access to specialized services such as visual-acoustic biofeedback. The proposed research will meet a public health need by expanding our basic understanding of perception-production relations in child speech while evaluating whether tasks involving perceptual training and biofeedback intervention are valid in the online modality. This translational research aligns with NIDCD’s mission to improve the lives of individuals with communication disorders, as it will explore the relationship between auditory-enhanced treatments and expand evidence for the online delivery of biofeedback intervention to sibilants, an additional class of frequently misarticulated sounds.